Administrative Supplement Related to Alterations and Renovations of an Outdoor Breeding Corral

PROJECT ABSTRACT
This application from California National Primate Research Center (CNPRC) is located on
the University of California (UC), Davis campus seeks to obtain federal funding in the amount
of $499,000 through the Administrative Supplements for Alteration and Renovation (A&R) to
purchase an overhead structure for a half-acre field corral and perform repairs to internal
cage structures. The CNPRC has 24 half-acre field corrals that provide housing for the rhesus
monkey breeding colony. Approximately 10 of these corrals were constructed in the 1970’s
and have required repair and maintenance over the past 40 years. Four of the corrals have
either structural problems and/or deteriorating shade structures that were put in place to
shelter the outdoor animals from both sun and rain. These canvas shade structures are
damaged by wind and the sun and need replacement every few years. The requested funds
will help purchase a steel overhead shelter for one corral that has a life span of 50 years.
The funds will also be used to repair internal cage structures such as capture chutes and
tunnels and feeding areas. The current conditions of these corrals prevent their utilization for
breeding and reduces the production capacity of the CNPRC. Each of the field corrals
potentially house approximately 150 rhesus macaques. These animals are a long-term
breeding resource and serve as a national resource for infants, juveniles, adults, and aged
animals for use in sponsored research by NIH investigators from throughout the United
States.
The field corral needing a replacement canopy was built in the early 1970’s to expand
production of animals for research and currently has a canvas canopy structure, which has
been damaged by sunlight and wind and needs to be replaced with a more permanent
structure. This project will renovate the current canvas cover to a free-standing 19' high, 100’
wide, and 60’ long steel-frame canopy cover (similar to patio structures) over approximately
one-quarter of a corresponding half-acre field corral, or 6,000 square feet. The structure will
include steel framing, metal roofing, and concrete footings.
The specific aims of the proposed project are to:
• enhance animal well-being and expand investigator access to healthy research
animals;
• provide animals a dry area for eating and shelter from the rain in the winter and
shade in the summer;
• provide veterinary and technical staff a dry area to conduct routine animal
health procedures and behavioral health assessments.
• renovate and repair internal cage structures for routine animal husbandry

Public health relevance
P51 ADMINISTRATIVE SUPPLEMENT TITLE. P51 Overhead Steel Canopy and Breeding Corral Renovation PROJECT NARRATIVE The application is seeking funding for alterations and renovations to one half-acre corral, by replacing a worn canvas shade structure with a steel overhead canopy. The new steel overhead canopy is similar to others that were successfully installed in adjacent enclosures in recent years. The new canopy will provide a better and more reliable shelter from the elements in the P51 rhesus macaques colony. The funding will also support renovation to the internal structures of the corral